Comparison of Symptom Burden/Toxicity, Neurocognitive Change, and Functional Outcomes in Pediatric Brain Tumor Patients Treated with Proton vs. Photon Radiotherapy.

PROJECT SUMMARY
Most children treated for cancer in the US will achieve long-term survival, and survivorship presents unique
challenges for this growing population. Pediatric brain tumor survivors, in particular, are at risk for neurocognitive
impairments, educational difficulties, social problems, and medical disabilities. Cranial radiation therapy is an
essential lifesaving treatment but is associated with cognitive decline. Proton beam radiation therapy (PBRT) is
one of the most promising recent advances in pediatric brain tumor treatment. The proposed medical advantage
of PBRT lies in the precision of radiation delivery with proton beams, depositing maximum dose to clinical targets
while minimizing radiation to surrounding tissues. By reducing dose to healthy brain tissue, PBRT may spare
cognitive functioning and reduce symptom burden better than conventional photon or x-ray irradiation (XRT)
leading to greater functional independence in survivorship.
The proposed Diversity Supplement Study leverages data collected on the Parent R01 at on-radiotherapy
(RT) time points to examine acute experiences of symptom burden and toxicity in this multi-national study.
Comparisons of prospectively assessed acute outcomes between PBRT and XRT pediatric brain tumor groups
have not been published to date, making this a novel study that will inform our understanding of RT modality
differences. The following aims, which map onto Aim 1 of the Parent R01, are proposed: (1a) to compare acute
symptom burden/toxicity by RT type (PBRT vs. XRT) in pediatric brain tumor patients and (1b) to examine risk
factors of symptom burden/toxicity during RT. The Diversity Supplement Study is within the scope of the Parent
R01 while also providing a clinically meaningful expansion of this line of research.

Public health relevance
PROJECT NARRATIVE Many consider proton beam radiotherapy (PBRT) to be a promising treatment for children with brain tumors as it may preserve functioning without sacrificing disease control. This Diversity Supplement extends the Parent R01, which is the first large-scale study to prospectively compare symptom burden, treatment toxicity, and neurocognitive change between patients treated with PBRT vs. conventional photon radiotherapy on comparable treatment protocols and to assess important measures of daily functioning that will quantify the clinical significance of any differences identified between groups in survivorship. Ultimately, this line of research is intended to: (1) help physicians and families better understand the relative effect of PBRT on symptoms and neurocognitive functioning to inform treatment decisions, and (2) provide functional outcome data to be used toward justifying or reconciling the high cost and access limitations currently associated with PBRT.